The pulmonary immune response induced by single and multiple exposures to combustion products of burn pit constituents

Abstract
Members of the Armed Services deployed in the Middle East were exposed to numerous environmental
toxicants, including emissions from open-air burn pits. Burn pits are designated areas on military sites for open
air combustion of trash and other unwanted items. Large amounts of waste are destroyed through burn pits.
The contents of burn pits are highly variable temporally within the same location and between locations, but at
least three components are present in most; plastics, military plywood and military cardboard. Burn pits contain
both smoldering and flaming combustion. In collaboration with colleagues at the EPA, we utilize a controlled
furnace to burn plastics and military plywood and cardboard at either smoldering or flaming temperatures. These
three components are burned either individually or as a mixture, and the complex combustion products are
analyzed in detail. Our studies show that single exposures of flaming combustion products of any component
or the mixture induce lung inflammation, whereas smoldering combustion products do not. Repeated exposure
to flaming combustion products of the mixture, which commonly occurs among military personnel, induce a small
increase in neutrophils compared to a single exposure when both were studied 24 hours after the final exposure,
but no change in lung injury. Importantly, the nature of the immune response changes after repeated exposures,
as measured both by mRNA of selected immune mediators and by multiplex assay of cytokines, chemokines
and other mediators. Unbiased analysis of the proteome present in the BAL fluid also reveals differences
between single and multiple exposures. Evidence of a change in the lung microenvironment toward Th1 immune
responses and a greater anti-oxidant capacity is present. The proposed study thus tests the hypothesis that the
lung's response to multiple exposures takes on a different nature than to a single exposure, reflecting adaptation
and resiliency by the lungs. Studies proposed in Aim 1 will characterize both the immune cell infiltrate in
bronchoalveolar lavage and lung tissue and the lung injury following a single exposure and multiple exposures
to burn pit combustion products. Mice will receive either a single exposure or five or ten exposures, 2 or 3 days
apart, of either combustion products of the mixture or saline (controls) and will be studied at 24 hours after the
final exposure. The number of epithelial and immune cells (neutrophils, macrophage subpopulations, T and B
lymphocytes, NK cells and their activation states) will be measured using flow cytometry. Markers of acute
inflammation, Th1 immune responses, anti-oxidant capacity, and lung injury and repair will be measured.
Studies in Aim 2 will determine the transcriptomes of lung bronchial and alveolar epithelial cells, neutrophils and
macrophage subpopulations following single compared to multiple exposures to burn pit combustion products.
These studies will use single cell RNAseq/CITE-seq of lung digests obtained 24 hours after the single or the fifth
exposure. Thus, studies will provide an understanding of the lungs' response to burn pit combustion products
experienced by members of our Armed Services and may suggest interventions to be pursued.

Public health relevance
Exposure to burn pits are a public health threat to those in the Armed Forces who are serving or have served in the Middle East and Africa. Our studies investigate the acute and chronic effects of exposure on lung health in studies of a mouse model that closely mimics the human exposure to burn pit toxicants, particularly the immune responses and the changes in the lung microenvironment that impact on the response. Our goal is to understand the critical pathways of the immune response that regulate the changes that occur during multiple compared to single acute exposure, with the expectation that mechanisms of lung resiliency and a therapeutically targetable pathway will emerge and will prove useful in modulating lung disease due to burn pit toxicants and to other environmental exposures.